Achieving FDA Approval & Commercial Readiness for Beacon-AUD: A Digital Diagnostic Medical Device for Alcohol Use Disorder

PROJECT SUMMARY
Excessive alcohol use and alcohol use disorder (AUD) contribute to numerous and severe health conditions,
including cancers, liver, and heart disease, and exacerbate existing conditions including diabetes and mental
illness. Early detection and diagnosis of AUD is critical to optimize patient outcomes. Routine assessment for
AUD, however, is simply under-performed. BEAM seeks to establish the standard for behavioral health diagnosis
and empower providers to advance proactive, patient-centered healthcare. In alignment with this mission, our
first diagnostic module, Beacon-AUD, mitigates the stigma, time constraints, and underperformance of the
assessment and diagnosis of AUD within clinical settings. Beacon-AUD can be administered in less than two
minutes, providing easy-to-understand results integrated directly with the provider's electronic medical record
(EMR). This innovative approach, and the successful completion of this proposal, will set Beacon-AUD as the
first FDA-approved software as a medical device dedicated to AUD diagnosis. Our funded Phase II STTR (R42
AA026794) for Beacon-AUD resulted in highly successful product
and implementation optimization, EMR
integration, and initial norming in a crowdsourced dataset. However, Phase II also identified four additional
objectives that must be obtained for full commercialization. Aim 1 will be dedicated to a multi-site clinical study
following feedback from the FDA on our pre-De Novo submission. In Aim 2, we will respond to physician-user
feedback collected in Phase II by convening an Expert Panel to develop consensus on AUD treatment options
to be delivered by Beacon-AUD following clinical diagnosis. Aim 3 will prepare all regulatory submission
documents in accordance with the requirements of the FDA and in coordination with an experienced regulatory
consultant. Finally, Aim 4 will initiate validation of Beacon-AUD’s economic value proposition to payors using
Health Economics and Outcomes Research (HEOR). At the conclusion of this CRP project, BEAM will have
completed the final steps for a market-ready Beacon-AUD as the first FDA-regulated software as a medical
device for rapid, valid, non-stigmatizing assessment of AUD. By addressing the existing barriers to diagnosis,
providing evidence-based clinical recommendations, submitting for FDA approval, and gathering a deep
understanding of market forces acting on diagnostic software, we envision Beacon-AUD as substantially
improving the identification and treatment of AUD in routine practice and being ready for full market adoption.

Public health relevance
PROJECT NARRATIVE Alcohol Use Disorder (AUD) impacts millions of US adults each year; however, consistent screening and diagnosis for AUD faces numerous challenges, including time constraints, provider training, and stigma. Fast, easy-to-use, and remote-compatible technology can increase and improve AUD identification and diagnosis, providing clinicians with needed information to improve evidence-based care. This Commercialization Readiness Pilot Program proposal aims to achieve regulatory approval for Beacon-AUD, a novel digital medical device for the diagnosis of AUD to lower barriers to early diagnosis and improve proactive treatment.